Efficacy and Mechanisms of Media and Storybook Interventions to Promote Children’s Early Literacy Skills via Caregiver Engagement

Project Summary/Abstract
This project aims to determine whether a media-based intervention targeting low- socioeconomic status
(SES) preschoolers and their caregivers can improve children's early literacy skills relative to a caregiver-led
shared-reading intervention, in line with two NICHD priority areas: (1) effects of technology and media on child
development and (2) school readiness in children from low-SES homes. The current proposal is situated in an
implementation science framework, aiming to identify barriers to implementing evidence-based practices and
adopting strategies to address these barriers and improve outcomes. In prior work, we found that a storybook
intervention with explicit print referencing improves children's early literacy skills; however, caregiver adherence
is often low. Here, we hypothesize that using educational media may circumvent or diminish barriers and promote
adherence, as media may be more readily incorporated into household routines and thus increase child exposure
to print references, a key mechanism for learning. This study addresses four specific aims: (1) To determine the
extent to which a media-based, caregiver-led early literacy intervention leads to higher adherence among low-
SES families relative to an aligned shared reading intervention (and the extent to which the media intervention
reduces barriers, which then leads to higher adherence), (2) To determine the extent to which a media-based,
caregiver-led early literacy intervention leads to greater improvement in literacy skills of children from low-SES
homes, relative to an aligned shared reading intervention, (3) To determine the extent to which effects are
mediated by higher adherence (i.e., intervention dose and intensity), and (4) To determine the extent to which
two potential moderators (child sex and caregiver self-efficacy beliefs) influence effects of intervention medium.
We also explore potential child-, caregiver-, and dyad-level moderators of intervention medium on early literacy
skills. This study uses a randomized controlled trial with three conditions: a caregiver-led media-based early
literacy intervention, a caregiver-led shared reading early literacy intervention, and a business-usual control.
Participants are 450 caregivers and 3.5 to 4-year-olds. Early literacy skills are assessed at pretest and posttest.
Social validity of the intervention is measured to test whether the media intervention circumvents barriers. Fidelity
of implementation is measured during the intervention. Follow-up visits at three, six, and twelve months tests
long-term effects. Aim 1 uses regression models to compare adherence and social validity across conditions,
and to predict adherence from social validity. Aims 2, 3, and 4 are addressed via regression models comparing
gains from pre- to post-test and two-level growth models examining growth in skills across follow-up time points.
This project is innovative as it seeks to understand mechanisms by which using media to address barriers to a
caregiver-led literacy intervention may be effective, capitalizing on the benefits of both educational media and
caregiver-led interventions and testing mechanisms underlying effects on literacy skills.

Public health relevance
Project Narrative By kindergarten entry, children from low-socioeconomic status (SES) backgrounds lag behind their peers from higher SES homes in early literacy and other school readiness skills and these gaps persist through high school. The goal of this study is to determine whether an intervention to support caregivers in engaging with their children while co-using educational media can improve children's early literacy skills, compared to an aligned shared book reading intervention and to no intervention. Given that early literacy skills predict children's later academic learning, this home intervention, which aims to shape the communication patterns surrounding a common, family-friendly activity, has the potential to positively influence the trajectory of low- income children's academic success.